5/6 HBCD Prenatal Experiences and Longitudinal Development (PRELUDE) Consortium

PROJECT SUMMARY/ABSTRACT
Brain development occurs at a rapid pace prenatally and throughout childhood, impacted by dynamic genetic
and environmental influences. Studies using advanced neuroimaging have provided significant insights into
brain development but have been limited by small sample size, especially for high-risk populations. Substance-
exposed infants are at particularly high risk for adverse outcomes; however, findings are inconsistent, making it
difficult to disentangle prenatal exposure effects from other adverse influences. The objectives of our HEALthy
Brain and Child Development (HBCD) Prenatal Experiences and Longitudinal Development (PRELUDE)
consortium are to characterize typical trajectories of brain development from birth through childhood,
measuring the influence of key biologic and environmental factors and their interactions on child social,
cognitive, and emotional development. We will assess how children prenatally exposed to opioids and other
substances, as well as environmental adversity, differ in those brain trajectories and outcomes. Our consortium
consists of six centers (Arkansas Children’s Research Institute, Case Western Reserve University, Cincinnati
Children’s Hospital, Children’s National Medical Center, University of North Carolina at Chapel Hill, and
Vanderbilt University) which have collaborated previously and have complementary expertise in neuroimaging,
neurophysiology, longitudinal clinical research, child development, substance exposure and addiction,
ethical/legal issues, and clinical care of high-risk infants/children. The PRELUDE consortium will recruit 680
pregnant women with substance use, 680 at-risk pregnant women without substance use, and 1360
comparison pregnant women representative of the general population to contribute to the overall HBCD study.
We will work closely with the other sites, the HBCD Consortium Administrative Core, and the HBCD Data
Coordinating Center to develop a comprehensive study protocol and ensure compliance of study workflow and
data transfer. Our consortium has an optimized research protocol and 4 specific aims: 1) Employ ethical and
evidence-based best practices to enroll and retain a diverse cohort of pregnant women into a longitudinal
study of infant/child brain development, oversampling mothers from high-risk backgrounds and those using
substances during pregnancy; 2) Engage a comprehensive array of maternal- and child-oriented community
stakeholders to identify community concerns and priorities regarding this research, minimize risks, and
promote long-term engagement of the recruited child-mother dyads; 3) Collect rich data to examine how
maternal health context and broader environmental factors may affect the maternal-fetal dyad and
neurodevelopment of children; 4) Capture key developmental windows during which maternal and
environmental factors may interact with brain and behavioral development of children. The insights from
these data will provide greater understanding of factors affecting early childhood brain development,
allowing targeted interventions and improved outcomes for mother-child dyads.

Public health relevance
PROJECT NARRATIVE Substance use in pregnant women has increased over the past decade, highlighting the importance of efforts to understand how environmental and other exposures during pregnancy affect brain development and child outcomes. The PRELUDE consortium for the HEALthy Brain and Child Development study will recruit 2720 pregnant women in the 2nd and 3rd trimester and follow their children to age 10, using neuroimaging, behavioral assessments, EEG, biosample collection, and assessments of parent-child interaction and the home environment. This research will lead to greater understanding of factors affecting early childhood brain development, allowing targeted interventions and improved outcomes for mother-child dyads.